Dynamic Strategies for the clinical management of HIV disease

See attached one-page Abstract of the Research Plan following Form Page 2.
RELEVANCE (See instructions):
We will answer key clinical questions about the management of HIV-positive patients by applying
innovative analytic methods to complex observational data. We will develop the methods, implement them,
show that they work, and make them available to HIV researchers.

Public health relevance
We will answer key clinical questions about the management of individuals with HIV by applying innovative analytic methods to complex observational data. We will develop the methods, implement them, show that they work, and make them available to HIV researchers. By generating novel methodology that combines causal inference and AI, this work will benefit the American people by expanding the applicability of healthcare data to identify better preventive and therapeutic interventions.